FAST-ET: Fast Automated Serial Tape-Enabled Electron Tomography

PROJECT SUMMARY
This project aims to develop a solution for high-throughput brain connectomics by integrating GridTape-based
automated section collection and handling with advanced serial electron tomography (ET). ET is an
indispensable tool for ultra-high resolution imaging, typically used to study very small regions in detail by
computationally reconstructing 3D volumes from 2D projections. Using intermediate voltage transmission
electron microscopy (IVEM), ET generates volumetric information through thick sections (up to 2 μm). By
combining ET of thick sections with automated section collection and handling, we aim to significantly advance
whole mouse brain connectomic imaging in terms of robustness and practicality, improving upon capabilities for
high- and multi-resolution imaging for mammalian brains, and more efficiently elucidating the organizational
principles of brain circuits. Our approach will further facilitate sample-preserving imaging, allowing for multi-scale
interrogations without sample destruction, thereby significantly reducing the risks associated with data
acquisition and amplifying the value of prepared samples. The efficacy of this solution will be validated using the
mouse cerebellum, providing insights into cell-to-cell communication within this brain region crucial for motor
control. The project will be driven by three complementary aims structured to: 1) Evaluate ET scalability by
assessing imaging conditions, lossless sectioning, and GridTape characteristics, 2) Develop tape-enabled serial
ET through the design and testing of a reel-to-reel tape system, a tape tilting system, and related software, and
3) Augment tape-enabled ET with advanced machine learning algorithms, energy-filtered TEM strategies (e.g.,
automated most-probable loss tomography (MPL)), continuous imaging, and modifications for large section
tomography. Deliverables from this work will include the development, testing, and troubleshooting of prototype
FAST-ET platform, critical reference datasets for the neuroscience community, and scalable metrics for
mammalian whole-brain connectomics. Our goal is to significantly advance understanding of brain function and
dysfunction with broad implications for neuroscience, engineering, and artificial intelligence.

Public health relevance
NARRATIVE The goal of this proposal is to advance the scalability and automation of electron tomography (ET) to achieve multi-resolution, large-scale imaging of the brain. By integrating automated tape-based sample handling, advanced ET technologies, and machine learning techniques for data acceleration and augmentation, we aim to comprehensively map neuronal circuits, and deliver a paradigm shift for generating mammalian whole-brain connectomes. Mapping the detailed organization and connectivity of the brain will provide critical insights into principles of neuronal circuit organization and a foundation for understanding how they are altered in neurodegenerative disorders.